Posaconazole: Retrospective Review of Clinical Use and Therapeutic Monitoring

Data collection of NIH clinical center patients who have received posaconazole has been completed. Abstracts have been accepted and presented as noted below: I am currently in the process of writing a manuscript. ACCP, October 2012 Jancel T, Penzak SR, Shaw PA, Malech HL, Freeman AF, Holland SM. Review of the use and therapeutic drug monitoring of posaconazole in adults. American College of Clinical Pharmacy (ACCP) Annual Meeting. October 2012. ICAAC, September 2011 Jancel T, Penzak SR, Shaw PA, Malech HL, Freeman AF, Holland SM. Review of the use and therapeutic drug monitoring of posaconazole in pediatric patients. 51st Interscience Conference on Antimicrobial Agents and Chemotherapy (ICAAC). Chicago, IL. September 2011. ICAAC, September 2014 Jancel T, Kumar P, Malech HL, Freeman AF, Zerbe C, Holland SM. Review of the use and therapeutic drug monitoring of posaconazole delayed-release tablets. 54th Interscience Conference on Antimicrobial Agents and Chemotherapy (ICAAC). Washington, DC. September 2014.